Administrative Core

PROJECT SUMMARY OF THE ADMINISTRATIVE CORE
Our thriving Center of Excellence for Natural Product Drug Interaction Research (NaPDI Center) has achieved
tremendous success in establishing rigorous and definitive approaches for the design and conduct of natural
product (NP)-drug interaction (NPDI) studies and advancing our understanding of pharmacokinetic NPDIs
precipitated by four carefully selected high priority NPs: green tea, goldenseal, cannabis, and kratom. The
success of the NaPDI Center reflects multiple inter-institutional and intra-institutional collaborations that worked
effectively and efficiently with logistical, fiscal, and intellectual support provided by the Administrative Core. Roles
and responsibilities of the Administrative Core are integrated into all NaPDI Center activities, at both the
programmatic and project levels, ensuring that prescribed project milestones are met and within budget.
Accomplishments of the Administrative Core derive from a lean leadership structure and regular, effective
communication between Center investigators. As detailed in this renewal application, we propose three SPECIFIC
AIMS that represent a continuation of existing Core functions with multiple innovations. AIM 1: the Administrative
Core will coordinate project activities of the investigators composing the three scientific Cores (Pharmacology,
Analytical, and Informatics) and their associated academic institutions, ensuring maximal scientific productivity
and fiscal cohesion. The Administrative Core will partner with NCCIH to establish a Steering Committee that 1)
oversees the NaPDI Center program, 2) monitors progress of the Interaction Projects and expansion of the data
repository and public portal, and 3) recommends changes in scientific direction when warranted. In addition, the
Administrative Core will ensure effective communication between Center investigators and the External Advisory
Panel by providing regular updates of project progress and tapping the Panel’s wealth of expertise in relevant
disciplines to inform strategic directions of the Center and help address specific project challenges. AIM 2: the
Administrative Core will work with the Informatics Core to develop and implement innovative metrics to evaluate
program success, completion of annual milestones, and impact of specific project outcomes on the scientific field
and public health and safety. AIM 3: the Administrative Core will provide leadership for the broad dissemination
of best practice methodologies and recommended approaches developed by the Center for the optimal conduct
of human mechanistic in vitro and clinical NPDI studies. These activities will include innovative approaches to
broaden outreach to national and international scientific communities. Our time-tested administrative team has
developed a highly effective operational paradigm that will ensure continued productivity of the Center and
translation of Center-generated data to improve public health.